ADVANCED MCMC ALGORITHMS FOR BIOMEDICAL DATA ANALYSIS

DESCRIPTION (Adapted from the applicant's abstract): Large and rapidly growing sequence and structural databases provide a vast new resource for the biomedical sciences. The usefulness of computational approaches to extract information from these databases to address some of the most difficult and important problems in molecular and structural biology has become increasingly apparent. However, these data often contain several characteristics that are well known to render them resistant to analysis, including presentations of missing data, the existence of likelihood or posterior surfaces with multiple local extremes, or the need to control the dimensional size of models used to describe these complex data. Progress has been made on some of these issues, most notably the missing data problem, through the use of Bayesian recursive algorithms, expectations maximization algorithms, and hidden Markov models (HMM) and MCMC sampling algorithms. However, the other issues remain largely unsolved. Recent advances in MCMC technology have opened up fresh approaches to these difficult data analysis problems. Specifically, the recent emergence of multi-scales MCMC algorithms which are effective in identifying optima in rough landscapes, and the development of reversible jump MCMC algorithms for inferences on the dimension of a problem, have initiated changes in this arena. In the last few months, a class of multistage MCMC algorithms, called simulated sintering, which permit Bayesian inference on rough landscapes including those inherent in many reversible jumping algorithms, present an opportunity for a breakthrough for these very difficult data analysis challenges. The aims of this research are to explore the development, adaptation, and application of these methods to some of the grand challenges of molecular and structural biology.